NARMS Cooperative Agreement Program to Strengthen Antibiotic Resistance in Retail Food Specimens

Project Summary
The New York State Department of Health (NYSDOH) Wadsworth Center (WC) public
health laboratory is committed to protecting and improving the health of New
Yorkers through laboratory testing analysis, investigations and research.
The specific aim of this project will be to improve detection of, and surveillance
for, antibiotic resistance for Salmonella, Campylobacter, Enterococcus, Aeromonas, and
Vibrio bacteria isolated from food products purchased from selected grocery stores.
Objectives will be to: 1) collect and test samples for Salmonella,
Campylobacter, Enterococcus, Aeromonas, and Vibrio bacteria utilizing
microbiological tests; 2) collect, analyze and exchange surveillance data on isolate
identifications and provide whole genome sequence data and serotyping analysis; 3)
ship isolates attained from meat and seafood samples for additional testing to FDA;
and 4) collaborate with FDA, Center for Veterinary Medicine (CVM), NARMS and state
laboratory partners.
Outcomes expected from this work include: 1) providing an increase in the
total amount of Salmonella, Campylobacter Enterococcus, Aeromonas, and Vibrio
isolates from retail meats and seafood that can be analyzed; 2) maintaining the ability
to compare results to surveillance data and exchange information and test results; 3)
providing an increase in the number of isolates submitted to the FDA; and 4)
increased collaboration and communication among partnering entities.

Public health relevance
Project Narrative The New York State Department of Health (NYSDOH) has been a leader in protecting and advancing the health of New Yorkers through a comprehensive network of public health activities and services. The complexity of the state, from densely populated urban, to rural and suburban areas, the diversity of the state with respect to race, ethnicity, and socioeconomic status, warrants a public health system that is comprehensive and flexible to govern the state’s public health successfully. To aid in the reduction of foodborne illness and prevalence of antibiotic resistance bacteria both locally and nationally the NYSDOH is seeking funding to improve detection of, and surveillance for, antibiotic resistant bacterial pathogens isolated from food products purchased from retail grocery stores